The Origin, Dynamics, and Function of Postnatal Beige Adipocytes

Obesity is expected to affect nearly 50% of adults in the United States by 2030 and is a major risk factor for type
2 diabetes, cardiovascular disease, and many types of cancer. Obesity is characterized by an accumulation of
white adipose tissue, which can become dysfunctional in the setting of chronic overnutrition, contributing to the
sequelae of excess adiposity. Mice and humans also possess thermogenic brown and beige adipocytes, which
convert chemical energy into heat and have been associated with potent anti-diabetic and cardioprotective
benefits. The metabolic effects of thermogenic adipocytes extend beyond energy dissipation, with these cells
also serving as a sink for toxic metabolites, suppressing inflammation and fibrosis, and secreting paracrine and
endocrine mediators. Murine beige fat shares significant similarities with brown fat described in adult humans,
with both displaying highly cold-inducible activity and a common molecular program. Thus, beige adipocytes in
mice are an attractive model system for dissecting the mechanisms underlying the broad benefits of thermogenic
fat. However, fundamental questions regarding the origin, dynamics, and function of these cells remain
unanswered. In studying crosstalk between the sympathetic nervous system and beige fat, we found that beige
adipocytes form at postnatal day 10, independent of sympathetic innervation and cold stimulation. Starting at
postnatal day 28, these cells suppress their thermogenic properties and become dormant, but can be reactivated
upon cold exposure in adults. We also discovered that dormant beige adipocytes possess heretofore
undescribed functional properties, protecting against tissue inflammation in obesity. Based on these findings, we
propose that postnatal beige adipocytes are developmentally hard-wired cells that become thermogenically
dormant in early adulthood and are reactivated to provide the major source of inducible beige adipocytes in
adults, while also serving as a central regulator of adipose tissue homeostasis. We will address this hypothesis
through two specific aims: (1) We will elucidate the origin and dynamics of beige adipocytes, using lineage tracing
models coupled with in vitro characterization and in vivo transplantation experiments to define the committed
postnatal beige fat cell progenitor and the tissue niche factors triggering these cells’ development. (2) We will
dissect the function of postnatal beige adipocytes in normal physiology and obesity using mouse models with
temporally regulated ablation of active or dormant postnatal beige adipocytes, along with single nuclear
transcriptomic datasets to define the molecular properties of these cells. We will also employ a new approach to
monitor and characterize interactions between active and dormant postnatal beige adipocytes and other adipose
tissue cell types. This proposal will provide a new conceptual understanding of beige adipocytes and the first
insights into the role of dormant beige adipocytes in adipose tissue and whole-body homeostasis. In addressing
key knowledge gaps in the field, findings from these studies could serve as the framework for targeting postnatal
beige adipocytes for the treatment of obesity, type 2 diabetes, and associated diseases.

Public health relevance
Project Narrative Beige adipocytes have anti-obesity and anti-diabetes actions in mice and humans. We have defined new roles for developmentally hard-wired postnatal beige adipocytes, but their source, trajectory, and functions remain incompletely understood. Uncovering the origin and dynamics of postnatal beige adipocytes and establishing their functions in normal physiology and in obesity would provide fundamental new insights into a key cellular regulator of tissue homeostasis and whole-body metabolism that could be harnessed to develop new therapies for obesity, type 2 diabetes, and associated diseases.